RANDOMIZED PROSPECTIVE TRIAL OF MAXIMUM THERAPY IN HEART FAILURE PATIENTS

The aim of this study is to test whether maximizing ACE inhibitor dose in patients with severe heart failure already on a standard dose of ACEI results in better exercise tolerance compared to adding hydralazine.